Discovery of synthetic flavonoids for the treatment of corneal injury

ABSTRACT
The cornea is an optically clear tissue that forms the front surface of the eye and accounts for nearly two thirds
of its refractive power. Corneal trauma/injury is a main cause for blindness worldwide. The current standard of
treatment, corneal transplantation, remains compromised by donor shortages and significant risks such as
infections and transplant rejection. The majority of corneal blindness is permanent due to scarring/fibrosis;
therefore, controlling the progression and state of scarring is crucial for the maintenance of vision. Surgical
techniques are improving; however, these procedures are very invasive and may have long-term complications.
Thus, there is a need for therapeutic interventions to reduce the need for corneal transplantation. Our group,
previously showed that a naturally occurring flavonoid, Quercetin, can regulate corneal fibrosis, extracellular
matrix assembly, and cellular metabolism. During our preliminary studies we investigated several commercial
Quercetin analogs and their ability to modulate corneal fibrotic and DNA repair markers. Subsequently, we
designed, synthesized, and tested seven novel synthetic flavonoids (sFNs) based on two different Quercetin
analogs. The goal of the proposed studies is to determine whether such novel sFNs can be discovered that
possess superior properties compared to naturally occurring flavonoids and are effective in mitigating or even
reversing corneal fibrosis. We propose one, targeted, and highly translational specific aim where we will employ
an iterative optimization process of design, synthesis, and evaluation to discover new sFNs that can be employed
to determine whether sFN treatment can significantly impact (reverse and/or prevent) corneal fibrosis. If
successful, the proposed studies will provide strong data, and justification, for future evaluation of our
compounds in live animal models with a goal to delineate the effects on corneal fibrosis. In addition, successful
completion of the proposed studies will justify and set the stage for continued drug discovery and development
efforts to advance sFNs as novel therapeutics for the ocular injuries/trauma.

Public health relevance
PROJECT NARRATIVE Corneal scarring is a major cause of blindness in the world today but its epidemiology is proven to be very complicated and dependent on a variety of factors, including trauma, infections, and inflammation. Currently, and for the last four decades, the only available treatment for corneal scarring is corneal transplantation; however, this therapy has significant side effects and concerns. We propose to determine whether flavonoids, and novel synthetic flavonoids (sFNs) can be developed and utilized as therapeutic agents to mitigate or reverse corneal scarring.